Inhaled nitric oxide in neonates with severe hypoxia

To determine the best dose of inhaled nitric oxide to improve oxygenation innewborns with severely low blood oxygen levels who are breathing 100% oxygen. Babies with structural heart disease (except patent ductus arteriosus, atrial septal defect, and ventricular septal defect) or any lethal congenital anomaly are not eligible for this study.